Development of Metagenomic RNA-Seq Standard Operating Procedure for Variant-agnostic Whole Genome Sequencing of SARS-CoV-2 isolates from Animal Samples

Abstract
The genetic diversity of the severe acute respiratory syndrome coronavirus-2 (SARS-CoV-2) in
non-human hosts is more poorly understood. Although whole-genome sequencing (WGS) has
found extensive application in characterizing the genetic diversity of SARS-CoV-2 isolates over
the past two years, current protocols are aimed solely at identifying mutants circulating in human
hosts. This approach could potentially miss new biologically relevant SARS-CoV-2 variants that
may emerge as this virus continuously interacts with disparate non-human hosts. The proposed
research, therefore, focuses on the establishment of a validated standard operating procedure
(SOP) to directly sequence and analyze SARS-CoV-2 in clinical animal specimens using the
metagenomic RNA-Seq approach. Compared with the most widely used multiplex PCR targeted
amplicon sequencing approach (MTA-Seq), this unbiased metagenomic RNA-Seq approach
faithfully covers the entire viral genome and increases the odds of detecting new and unique
variants that may not be present in human populations.
We will use archived SARS-CoV-2 positive samples originated from diagnostic cases to evaluate
two novel library preparation systems, which are known either for the universal reduction of host
background (Zymo-Seq Ribo-Free Total RNA kit) or for enhancement of viral genome
amplification sensitivity with single primer isothermal amplification (SPIA) (Revelo RNA-Seq
Library Kit). The libraries will then be sequenced on both the Illumina iSeq and MiSeq
platforms. We will compare the performance of both kits for WGS on the basis of sequencing
depth, genome coverage, sequencing uniformity, and detection limits. Bioinformatic analyses
will be performed in the public Galaxy server and its GalaxyTrakr instance. The fully validated
SOP developed from this project will be submitted to FDA Vet-LIRN for distribution to other
member laboratories. On completion, this work will significantly enhance the capabilities of Vet-
LIRN laboratories and strengthen collaboration across the network.

Public health relevance
Relevance to Public Health Poor proof-reading activity of viral RNA polymerases ensures that all RNA viruses practically exist as a swarm of genetically distinct variants called quasispecies. Under immune selection pressure imposed by vaccination or natural infection, the fittest variants of an RNA virus like SARS-CoV-2 will escape and become the dominant species that continue to propagate the pandemic within an infected population. The interaction of such new variants with the infected host population will determine the trajectory of a pandemic. To date, standard whole genome sequencing protocols have been established to investigate SARS-CoV-2 genomes in human samples. This has ensured that new variants can now be detected and tracked to plan mitigation strategies before they become dominant. The types of selection pressure that drive the evolution of SARS-CoV-2 quasispecies in non-human hosts have not been fully explored. However, it is conceivable that disparate selection pressure operating in different non-human species could lead to the emergence of novel variants that may trigger hitherto unknown pathogenic mechanisms if such variants reinfect humans. Establishing a harmonized and validated SARS-CoV-2 WGS SOP will enable FDA Vet-LIRN laboratories to detect and analyze SARS-CoV-2 variants with WSG directly from clinical animal samples. Using the validated SOP across the board will ensure data quality and ease of comparison which is important to monitor and control the SARS-CoV-2 pandemic through early detection of novel variants of non-human origin.